International research training program in vaccine development and public health

ABSTRACT
This is a competing renewal application for a Fogarty International Center-sponsored Global Infectious
Disease Research Training Program in vaccine development and public health between the International
Centre for Diarrhoeal Research in Dhaka, Bangladesh (icddr,b) and the Massachusetts General Hospital
(MGH) in Boston, Massachusetts. Now in its 20th year, this training program has focused on long-term
training of young investigators at the icddr,b. In this renewal application, we propose three revisions to
meet identified evolving needs in Bangladesh and to take this training program to the next level: (1) now
that a number of trainees have successfully completed their pre-doctoral, doctoral and post-doctoral
experiences, we will add a focus to mentor junior faculty and senior postdoctoral fellows as they obtain
independent grant funding in Bangladesh, (2) we will expand our successful Dhaka-based program to
include candidates from the southeast of the country through the Bangladesh Institute of Tropical and
Infectious Diseases (BITID) in Chittagong, Bangladesh, and to the northwest of the country through
Rajshahi University in Rajshahi, Bangladesh to expand opportunities beyond the capitol, and (3) we will
expand our faculty to include Bangladeshi experts in respiratory, viral and emerging diseases as mentors
to meet evolving needs. We will continue to focus on in-country training in Bangladesh, to include
training tracks in both laboratory sciences and public health investigation, and to include trainees at a
range of career development stages. The research platform upon which training would occur is based
upon active and successful NIH and other collaborative projects between the co-program directors for
this training program, Dr. Firdausi Qadri, Senior Scientist/Head, Immunology Laboratory, icddr,b, and Dr.
Edward Ryan, Division of Infectious Diseases, Massachusetts General Hospital and Harvard University,
as well as collaborations across faculty members. We propose to continue to train individuals through
both degree and non-degree programs, the former through collaborative arrangements with the James P.
Grant School of Public Health-BRAC University in Dhaka, Bangladesh (Master of Public Health Program),
and in focused laboratory research to support Master of Science and Ph.D. degree candidacy in
Biochemistry and Molecular Biology, Dhaka University, and Master of Science degree candidacy at
BRAC University. We also propose to continue to include long-term non-degree training, including of
new individuals from BITID and Rajshahi to train in Dhaka. We have assembled faculty with expertise in
laboratory sciences, infectious diseases and public health, and the goal of this program is to continue to
meet evolving research and public health needs in a sustainable manner in Bangladesh through
individual and institutional capacity building.

Public health relevance
NARRATIVE This is a competing renewal application for a D43 Fogarty International Center-sponsored Global Infectious Disease Research Training Program in Vaccine Development and Public Health between the International Centre for Diarrhoeal Disease Research in Dhaka, Bangladesh (icddr,b), and the Massachusetts General Hospital (MGH) in Boston. The program focuses on long-term training in laboratory sciences and public health, includes both degree and non- degree programs, and provides individual and institutional capacity building in Bangladesh. The program builds upon ongoing and active scientific collaborations between the icddr,b and MGH, including on Vibrio cholerae, typhoid fever, and enteric infections, as well as adding training in respiratory infections and emerging pathogens, with a goal of continuing to build local capacity in biomedical investigation of host-pathogen interactions and vaccine development in Bangladesh.